Immune modulating T cell therapy for lung cancer

Background and Innovation: The studies proposed here aim to develop a novel T cell-
based platform for delivering the cytokine Interleukin 12 directly to lung cancer tumors. We
have developed novel CAR-T cell engineering constructs targeting two tumor associated
targets, mesothelin and C3d. We also utilize a unique form of adoptive transfer that maintains
immune function and we have incorporated a novel drug inducible gene expression system to
enhance user control, safety, and therapeutic index. Significance and Impact to Veterans
Healthcare: Lung cancer contributes to more Veteran mortality than prostate and colon cancer
combined. Immune modulating therapies have been the most promising treatments for lung
cancer to emerge in the last several decades. These studies will explore new cell therapy
products that will be used to treat lung cancer in Veterans.
Path to translation/implementation: The studies outlined in this application will provide pre-
clinical validation of this cell therapy product by validating the safety and utility of the targeting
CD8+ CAR-T cells to target C3d and Mesothelin. Furthermore, it will provide pre-clinical
assessment of the novel user-controlled gene expression platform. Finally, the Aim 3 studies
will provide a translational framework by validating unique aspects of manufacturing and
quality control that are specific to this innovative cell therapy product. We anticipate that these
studies will lead to an investigational new drug application and opening of phase 1 clinical
trials for Veterans fighting lung cancer.

Public health relevance
A major goal of my research program is to develop cell therapies for malignancies that burden our Veterans. This proposal explores a novel cell therapy developed by our laboratory to target lung cancer with T cells that have been armed to deliver anti-cancer cytokines. We hypothesize that targeted-delivery of therapeutic peptides in a user controlled manner will stimulate anti-tumor immunity and promote adaptive immune surveillance of tumors. This proposal seeks to explore the utility of targeting two tumor associated markers Mesothelin and Complement C3d, with a CD8+ CAR-T cell product delivering the cytokine IL12. In addition to conducting studies in pre-clinical models of lung cancer. These studies will be aimed at defining a translational framework for clinical grade manufacturing of this novel cell product enabling future clinical trials.